EVALUATION OF CHRONIC TOTAL PARNETERAL NUTRITION ASSOCIATED BONE DISEASE

Propose an open ended study in adult subjects on chronic TPN. This study will involve 24 hour parathormone profile on and off calcium supplementation in the TPN, 2 hour parathyroid challenge test, measurement of bone dynamics by Positron Emission Tomography (PET) scan with 18F Fluoride ion, Bone density by Dual Energy X-ray Absorptiometry (DEXA) scan and bone histopathology.